Cancer Center Administration

ADMINISTRATION – ABSTRACT
The University of Hawai‘i Cancer Center (UHCC) Administration plays an essential role in creating an
environment that fosters collaboration, fiscal stability, and groundbreaking advancements in cancer research,
education, community outreach, and patient care. Our mission is to significantly reduce the burden of cancer in
Hawai‘i and the Pacific. With a dedicated team, UHCC Administration supports the Cancer Center’s Senior
Leadership in driving the development and implementation of our dynamic strategic vision, planning and
evaluation efforts. Led by the Associate Director for Administration (ADA), our exceptional administrative team
comprises Facilities Management, Fiscal Administration, Grants Administration, Human Resources, Human
Subject Compliance, and Information Technology. Together, we collaborate closely with key UHCC
components, including Community Outreach and Engagement (COE), Cancer Research Training (CRT),
Clinical Trials Office (CTO), Shared Resources, and the Cancer Biology (CB) and Population Sciences in the
Pacific (PSP) Research Programs. By leveraging these collaborations, we facilitate and propel UHCC’s
leading-edge research initiatives. Administration oversees an annual operating budget of $49.1 million,
sourced from a diverse range of funding streams, including state funds, university support, hospital affiliations,
philanthropic contributions, extramural grants, and the Cancer Center Support Grant itself. This financial
stewardship enables us to drive transformative research while ensuring strategic alignment with University,
State, and National priorities. Effective coordination and communication are the cornerstones of our
administration’s success. We maintain regular dialogue among team members and Senior Leadership, guided
by the collective group’s expertise and vision. Additionally, we oversee critical aspects such as Membership
policies, operations of the Shared Resources and core research facilities, work order prioritization, pricing,
chargebacks, member subsidies, auditing, user satisfaction, and quality control. Our commitment to excellence
extends to other crucial CCSG activities, including data reporting to the National Cancer Institute, coordination
of Developmental Funds, and administration of pilot projects. UHCC Administration serves as the central hub
for strategic, administrative, and financial planning, driving UHCC towards exceptional achievements in cancer
research, education, community engagement, and patient care. Our dedication to innovation, collaboration,
and fiscal stewardship positions us as an institutional leader, inspiring transformative advancements in the fight
against cancer